The role of the inflammatory microenvironment in Acellular Nerve Allografts (ANAs) repairing nerve gaps

PROJECT SUMMARY/ABSTRACT
Reconstruction of peripheral nerve gap injuries continues to pose a challenge in the clinic due to their
significant long-term functional morbidity. Multiple surgical approaches have been developed to promote
nerve regeneration across a damaged nerve with a gap. In the clinic, nerve autografts are considered the
standard of care in treating nerve gaps due to their superior capacity in promoting nerve regeneration.
However, the use of nerve autografts is limited by their availability, increased surgery time, loss of nerve
function from the lost nerve and donor site morbidity. Acellular nerve allografts (ANAs) have been proposed
as a clinical alternative to autografts in repairing nerve gaps due to their capability in promoting regeneration
across short gaps (< 3 cm). ANAs are allogenic nerves that are chemically processed to remove the cells,
reducing immunogenicity, while maintaining the extracellular matrix (ECM) that will allow cell migration into
the ANA and subsequent nerve regeneration. However, unlike autografts, ANAs do not support regeneration
across long defects (> 3 cm). The reason why long ANAs do not promote regeneration or regenerate poorly
is not completely understood. Previous studies have demonstrated the critical role of inflammatory cells,
such as macrophages and T cells, in regulating and promoting the early stages of nerve regeneration in
ANAs (before 4 weeks post-surgery). Specifically, macrophages will promote angiogenesis and T cells will
promote axonal myelination. However, when compared to short ANAs capable of robust regeneration,
preliminary data shows an increase in the expression of pro-inflammatory cytokines and changes in the
morphology of blood vessels in long ANAs at the later stages of nerve regeneration (between 4- and 8-
weeks post-surgery). The increase in the expression of pro-inflammatory cytokines and the changes in the
morphology of blood vessels happen after angiogenesis has occurred and axons have started migrating into
the ANAs. These changes suggest that a pro-inflammatory environment develops inside long ANAs in the
later stages of nerve regeneration, and this correlates with changes in the morphology of blood vessels and
a decrease in the number of myelinated axons. We hypothesize the state of chronic inflammation in long
ANAs is disrupting the regenerative microenvironment in long ANAs. In brief, the proposed research aims
to characterize and compare the inflammatory microenvironment that develops in the later stages of nerve
regeneration in long ANAs with the microenvironment in the regenerated short ANAs and autografts. This
project also explores the effect of reducing inflammation in long ANAs, using a pharmacological intervention,
on axonal regeneration. An integral part of this study is to identify the cell subpopulations promoting the pro-
inflammatory microenvironment in long ANAs. An in-depth analysis of these cell subpopulations may provide
specific molecular targets used to develop therapies aimed to promote nerve regeneration in long ANAs.

Public health relevance
PROJECT NARRATIVE Peripheral nerve injuries (PNIs) account for approximately 3% of trauma cases in the clinic, which translates into an expenditure of approximately 150 billion dollars spent in annual care due to the increased morbidity and decrease in the patient’s quality of life caused by PNIs. An alternative to promote nerve regeneration across an injured nerve resulting in a gap are Acellular Nerve Allografts (ANAs), which are processed allogenic nerves that promote regeneration across short gaps (< 3 cm) but fail to promote regeneration across longer gaps (> 3 cm). The goal of this research is to identify and compare the subpopulations of cells inside short and long ANAs and autografts, identify the cells promoting the inflammatory microenvironment in long ANAs, and reduce inflammation in long ANAs to observe the effects of decreasing inflammation on axonal regeneration and to further develop therapies promoting nerve regeneration across long ANAs.